Disparities in Immuno-oncology Outcomes in Detroit (DIODE)

Project Summary
This application will address cancer health disparities in Black residents of metropolitan Detroit, specifically
evaluating racial differences in genetic regulation of anti-tumor immunity in HER2+ breast cancer as an example
of the type of transdisciplinary work that will be catalyzed through the robust grant-planning infrastructure
developed in this P20. Black women with HER2+ breast cancer have substantially poorer outcomes overall and
among those treated with trastuzumab compared to White patients, even after controlling for clinical and
sociodemographic factors, suggesting biologic factors may also contribute. Endogenous adaptive immunity may
be a requirement for sustained tumor protection after monoclonal antibody treatment, and the role of genetic
regulation of immune tolerance, autoimmunity, and tumor immunity is well documented. Further, there is strong
evidence for racial differences in both immune pathway genetic variation and the tumor immune
microenvironment. A better understanding of the mechanisms regulating response to anti-HER2 antibodies is
critical for the development of improved clinical strategies, and the inclusion of a diverse patient population and
consideration of group- and individual-level genetic differences is essential for ensuring that these strategies are
equitable. We have assembled a strong multidisciplinary team of investigators committed to understanding the
biological underpinnings of racial disparities in cancer. The overarching goals of this P20 are (1) to identify
ancestry-specific genetic regulators of macrophage function and response to anti-HER2 antibody therapy that
potentially underlie racial differences in response to this targeted immunotherapy and (2) to establish a robust
infrastructure to support and develop innovative, productive immuno-oncology and health disparities research
collaborations. The application comprises one Research Project and an Administrative Core at an NCI-
designated comprehensive Cancer Center in Detroit, Michigan, where the majority of census tracts are medically
underserved areas based on HRSA definitions. The aims of this P20 are (1) to accelerate translational research
to reduce racial disparities in HER2+ breast cancer outcomes by characterizing race-specific immune profiles
with respect to the tumor environment and host genetic background to determine their contribution to response
to treatment with anti-HER2 antibody therapies and (2) to strengthen the existing programmatic structure to
facilitate intersectional, translational research on immuno-oncology and the biology of cancer health disparities,
achieve R01/P01-level funding, and ultimately reduce cancer health disparities in immuno-oncology outcomes.
This work will provide the basis for moving towards a more race-inclusive, equity-focused precision medicine
approach to the use of immunotherapies to improve overall treatment response, identify novel biomarkers, and
reduce racial disparities in outcomes.

Public health relevance
Project Narrative A better understanding of the mechanisms regulating response to anti-HER2 antibodies is critical for the development of improved clinical strategies, and the inclusion of a diverse patient population and consideration of group- and individual-level genetic differences is essential for ensuring that these strategies are equitable. This work will provide the basis for moving towards a more race-inclusive, equity-focused precision medicine approach to the use of immunotherapies to improve overall treatment response, identify novel biomarkers, and reduce racial disparities in outcomes.